Biostatistic and Patient Registry Core

PROJECT SUMMARY/ABSTRACT:
The Biostatistics, Bioinformatics and Patient Registry Core provides statistical and bioinformatics collaboration
and data management support for each of the SPORE Projects and the research projects initiated through the
Breast Cancer SPORE Developmental Research Program and the Career Enhancement Program. Each
project has a biostatistician and/or bioinformatician embedded into its research team with the breast cancer
content knowledge to understand the central hypothesis being tested and the analytic expertise to ensure the
development of a study design which can generate data to address the questions posed as well as ensure the
application of or development of statistical and bioinformatics analysis techniques that are appropriate to
assess the central hypothesis.

Public health relevance
PROJECT NARRATIVE The Biostatistics, Bioinformatics and Patient Registry Core is comprised of individuals with expertise in biostatistics and/or bioinformatics as well as understanding of factors that impact the development and growth of breast cancer. Their efforts in developing study designs and analysis plans to evaluate the research hypotheses ensures the issue of confounding factors is addressed, reliable and reproducible measurement techniques are employed, emerging scientific insights are incorporated into ongoing studies, and a sufficient number of patients/specimens/mice are utilized to draw conclusions. The care in which studies are designed, conducted, analyzed, and interpreted will impact whether the results are seen as providing insights that should be acted on and further built upon or not.